Core A: Administrative Core

ABSTRACT
(Core A)
Administrative Core
The Projects and Cores of this Program will be distributed across three Universities, the University of Alabama
at Birmingham (UAB), the University of Minnesota (UMN), and the University of Texas Southwestern (UTSW).
The Administrative Core (Core A) will work closely with Dr. Jay Zhang to provide the leadership and
organizational structure needed to maximize the synergy of this highly integrated and collaborative Program.
The activities of Core A are summarized under the following specific aims (SAs) and sub-Aims: SA1. Provide
leadership and promote synergy among Projects and Cores. The Administrative Core will lead and
coordinate the activities of all Projects and Cores in this PPG. SA2. Maximize communication among Program
Leaders, Trainees, and Advisors. Core A will lead and ensure the success of this collaborative Program for an
unrelenting commitment to maximum communication among all involved personnel, including Project and Core
Leaders, trainees, and staff, as well as members of the Steering and Scientific Oversight Committees and the
Internal and External Advisory Boards. SA3. Manage the administrative, fiscal, and compliance
responsibilities of all Projects and Cores. SA3.1. Ensure compliance with all University, State, and Federal
oversight agencies. SA3.2. Manage Program finances. And SA3.3. Assist Project Leaders, staff, and trainees
on an as-needed basis to provide routine administrative support and assist with other program-related activities
such as facilitating the hiring of new research staff and trainees, and coordinating the exchange of cell lines,
antibodies, plasmids, viral vector delivery systems, transgenic/knockout mouse lines, and other tools, reagents,
or protocols. Core A will also lead and maintain the exchange program for student and postdoctoral trainees
among Project laboratories, which will accelerate both the trainees' career development and the pace of scientific
discovery.

Public health relevance
NARRATIVE (Core A) Administrative Core The Administrative Core (Core A) will work closely with Dr. Jay Zhang to provide the leadership and organizational structure needed to maximize the synergy of this highly integrated and collaborative Program, the activities of which are summarized under the following specific aims (SAs) and sub-Aims: SA1 - Provide leadership and promote synergy among Projects and Cores - The Administrative Core will lead and coordinate the activities of all Projects and Cores in this PPG; SA2 - Maximize communication among Program Leaders, Trainees, and Advisors - Core A will lead and ensure the success of this collaborative Program for an unrelenting commitment to maximum communication among all involved personnel, including Project and Core Leaders, trainees, and staff, as well as members of the Steering and Scientific Oversight Committees and the Internal and External Advisory Boards; and SA3. Manage the administrative, fiscal, and compliance responsibilities of all Projects and Cores - Ensure compliance with all University, State, and Federal oversight agencies.